Identifying Transdiagnostic Intervention Targets for PTSD-SUD Comorbidity in a Vulnerable Population: A Mixed-Method Study

Project Summary
This study aims to identify transdiagnostic mechanisms of posttraumatic stress disorder (PTSD)-substance use
disorder (SUD) comorbidity among trauma-exposed transgender and gender diverse (TGD) adults.
Significance: TGD populations are virtually absent from PTSD-SUD research despite the alarming and
disproportionately high rates of exposure to violence, PTSD, and SUD observed in this population. Existing
theory suggests that these disparities are driven by cumulative exposure to stigma associated with having a
minoritized gender identity (i.e., gender minority stress). To inform the development of integrated PTSD-SUD
interventions for TGD and other minoritized people, research is needed to identify transdiagnostic,
culturally-congruent mechanisms of PTSD-SUD risk in the context of chronic exposure to minority stress.
Objectives and methods: Chiefly, the proposed study is designed to clarify how population-level PTSD-SUD
disparities manifest psychosocially (i.e., via daily behaviors and internal/external experiences) and
physiologically (i.e., within the body) to inform the development of evidence-based, integrative PTSD-SUD
treatment principles. Leveraging the resources and baseline data of an existing parent study (SC3 GM136580;
PI: Berke), I will recruit 70 TGD adults into a two-part study. Following a baseline biopsychosocial assessment
(i.e., clinical interview, salivary stress hormone collection, self-report surveys), participants will complete
ecological momentary assessment (EMA) for 14 days to assess patterns and predictors of daily co-fluctuation
in exposure to gender minority stress (e.g., discrimination), substance use, and PTSD symptoms. This will be
achieved by characterizing concurrent and prospective associations of daily co-occurrence among
discrimination exposure, substance use, and PTSD symptoms (Aim 1) and identifying transdiagnostic
mediators (i.e., internalized stigma, emotion dysregulation; Aim 2) and physical health risk correlates (i.e.,
chronic disease prevalence, stress hormone reactivity; Aim 3) of these associations. Innovation: This study
leverages a novel, unified biopsychosocial framework that accounts for relevant biological (e.g., stress
response dysregulation), psychological (e.g., emotion dysregulation), and socio-environmental (e.g., stigma)
factors that shape PTSD-SUD risk in this population. Identifying modifiable risk factors that cut across PTSD,
SUD, and the conditions of gender minority stress in which they co-occur will directly inform future
development of transdiagnostic, integrated PTSD-SUD intervention frameworks for TGD people by yielding
rich biopsychosocial data on clinical risk factors for PTSD-SUD comorbidity among TGD people. Findings from
the project will also set the stage for research and intervention paradigms that benefit all minoritized
subpopulations that are disproportionately impacted by identity-related violence by promoting a shift toward
more patient-centered approaches to health equity interventions. Proposal relevant to NOT-MD-19-001.

Public health relevance
Project Narrative Despite the high incidence of posttraumatic stress disorder (PTSD), substance use disorders (SUD), and chronic physical health problems among transgender and gender diverse (TGD) populations, research that can inform the development of transdiagnostic, integrated PTSD-SUD interventions for this population is lacking. The proposed dissertation study will address this clinical science gap by utilizing ecological momentary assessment to identify transdiagnostic mechanisms of co-occurrence among gender minority stress (e.g., TGD-based discrimination), susbtance use, and PTSD symptoms in a sample of trauma-exposed TGD adults, and will be among the first to utilize measures of neuroendocrine stress reactivity to examine physiological and physical health consequences of PTSD-SUD co-occurrence in a high-risk population. This study is consistent with NIDA priorities for research on social determinants of health and will inform the development of patient-centered models of care for minoritized populations more broadly by identifying specific and modifiable clinical targets that cut across experiences of chronic stigma-related stress, PTSD, and SUD in a vulnerable population.